SCGE Disease Models Studies Supplement: Development of LNP-mediated based editing to treat Leber Congenital Amaurosis (LCA) for vision restoration in mouse model

Abstract
Genetic blindness is prevalent with limited treatment options. Despite tremendous progress in the
development of editing technology as potential therapy for blindness, the ability to deliver the editing
complex into the retina for efficient editing remains a major challenge. The current prevailing method of
delivery of editing machinery is by viral vectors especially AAV. For AAV vectors, issues such as
immunogenicity, genome integration and long-term effect remain a safety concern. Further, more
complexed editing strategies including base editing (BE) and prime editing (PE), require the packaging of
multiple components into different AAVs, which further limits their efficiency. This proposal is to use
lipid nanoparticles (LNP) we have developed in the parental SCGE program for the mRNA delivery of a
base editor (ABE) to repair the mutation in a Leber Congenital Amaurosis (LCA) mouse model rd12 that
harbors a human mutation for the recovery of vision. We have previously demonstrated that the LNP
mediates the delivery of Cas9 mRNA-gRNA that targets the retinal pigment epithelium for efficient
editing. We have further demonstrated the feasibility of the LNP delivery of base editing complex by
mRNA in a mouse model. Combined, we will evaluate the application of new LNP for mRNA delivery of
the base editor and mutation correction by local subretinal injection, and correlate with the functional
restoration of vision in the rd12 mice. The success of the project will enable LNP-based transient delivery
of editing machinery to treat genetic blindness due to RPE mutations efficiently and safely.

Public health relevance
Project Narrative The proposal is designed to test the application of lipid nanoparticles (LNPs) identified from our SCGE parental grant to deliver base editing complex by mRNA to treat the mouse model of human genetic blindness Leber Congenital Amorosas type 2 for vision restoration. The study will establish the utility of LNP for the delivery of editing agents to treat genetic diseases, opening up a new avenue for transient and safer editing therapy for human diseases.